Bioactive Injectable Cell Scaffold for Meniscus Injury Repair in a Large Animal Model

SUMMARY ABSTRACT
Meniscal tearing is a significant risk factor for the development of posttraumatic osteoarthritis (PTOA). The long-
term goal of this project is to develop an innovative biologic therapy to improve meniscus tear healing for the
prevention of PTOA. Our laboratory has demonstrated the efficacy of utilizing cartilage-derived progenitor cells
(CPCs) to stimulate healing of meniscal tears in a small animal model. In efforts to translate our success in small
animals to a clinically relevant large animal model, we will optimize and implement a bioactive tear interfacing
fibrin hydrogel (FibroGel) that is laden with CPCs and infused with the chemokine Stromal Cell Derived Factor-
1 (SDF-1) and the small molecule Kartogenin (KGN), which collectively increases CPC retention at the tear site
and increases their chondrogenic matrix synthesis, respectively. The objectives of the proposed study are:
To optimize FibroGel as a novel biologic therapy for meniscus tear repair; (2) To determine its efficacy for
stimulating tear reunification and reduction of PTOA severity; and (3) To collect biocompatibility data throughout
the study to aid in clinical translation of this technology. There are three independent specific aims: (I) Optimize
cellular and bioactive components of FibroGel to produce robust fibrocartilage matrix re-synthesis to bridge and
reunify meniscus tears; (II) Evaluate the efficacy of using FibroGel for improving meniscal fibrocartilage healing
in a preclinical large animal model; and (III) Determine the efficacy of FibroGel-augmented meniscus repair in
attenuating PTOA in the knee. The research design will employ a meniscus tissue explant model to optimize
FibroGel in order to maximize cell retention and chondrogenic matrix re-synthesis at the tear site, as well as
increase the strength of tissue reintegration/reunion at the tear site. A porcine model of meniscal injury will be
used to examine the short- and long-term efficacy and biocompatibility of FibroGel. Outcome assessments will
include evaluation of meniscus tear healing, evaluation of PTOA severity as determined by biomarker analysis,
gait asymmetry analysis, and macroscopic/microscopic assessment of the articular cartilage and synovium
following FibroGel treatment. Successful completion will have a positive impact by facilitating the development
and translation of a new strategy to stimulate meniscus injury repair through the use of cellular biologics. This
project is relevant to the mission of NIAMS because it seeks to find innovative ways to treat musculoskeletal
injuries and prevent arthritis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will fill knowledge gaps that can help lay the groundwork for the development of innovative and effective biologic therapies for meniscus injury repair in order to delay/prevent degenerative joint disease. This research is aligned with the NIH’s mission that pertains to seeking fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to reduce illness and disability.